Using Road Traffic Data to Identify COVID-19 Priority Testing Locations in Southern California

1 Project Summary 2 Without a vaccine or effective treatment, there is an urgent need for performing widespread 3 COVID-19 testing to control disease spread. However, complete population testing is 4 prohibitively challenging as testing supplies are limited and require trained health staff which 5 could be better used in caring for those confirmed to be infected. It is therefore critical to focus 6 testing in high-priority areas, where tests are likely to capture positive cases. Identifying infected 7 individuals quickly as tests become more widely available will provide crucial information on 8 overall disease prevalence to inform future disease control efforts. 9 We can help identify areas of potentially high disease prevalence by synthesizing and using 10 traffic patterns, as transportation patterns may shed light on possible transmission patterns in 11 Los Angeles County (LAC). We propose using the USC Archived Data Management System 12 (ADMS), which collects and synthesizes traffic data, to create an epidemic model informed by 13 up-to-date origin-destination traffic information. We will use the model to identify which of the 26 14 health districts in LAC are at highest risk for unidentified cases and optimally locate testing sites 15 within these regions. This allows our recommendations to incorporate change in transportation 16 patterns as social distancing recommendations evolve. Specifically, we will partner with the LA 17 County Department of Public Health to: 18 1. Use road sensor data to analyze traffic patterns in Los Angeles County to understand 19 the impact of social distancing guidelines on population flow. 20 2. Develop a dynamic transmission network model of COVID-19 using results from Aim 1 21 and disease parameters from the medical literature to identify high priority districts for 22 testing. 23 3. Develop a location model to optimally place drive-through testing sites in these districts. 24 The proposed work will use methodology from infectious disease transmission models, traffic 25 data, and facility location models together in a novel way. Not only will we provide much needed 26 insight using empirical data into population flow dynamics in the context of social distancing 27 recommendations, we will shed light on infectious disease modeling more generally. By creating 28 a compartmental network model with realistic, time-varying travel patterns in a large 29 metropolitan area, the proposed work will further our understanding of the impacts of structural 30 modeling assumptions on disease prediction.

Public health relevance
Project Narrative We propose using up-to-date traffic pattern data collected from road sensors throughout Los Angeles County to build a compartmental disease model of COVID-19 informed by dynamic population flow patterns. We will use the model to identify which health districts in Los Angeles (LA) county are at highest risk for unidentified cases and partner with the LA County Department of Public Health to optimally locate testing sites within these regions. The proposed work would use methodology from infectious disease models, traffic data, and facility location models together in a novel way, and to our knowledge, no prior work has leveraged such detailed traffic information over such a large urban area to inform disease control efforts.